NHLBI - RISK MANAGEMENT FRAMEWORK SERVICES TASK ORDER 2 (TASK AREA 2)

The objective of the BPA is to procure cybersecurity services to perform tasks associated with implementation of the NIH RMF with the ultimate outcome of achieving and maintaining NHLBI and partnering entities information systems’ Authorities to Operate (ATO). Through the Blanket Purchase Agreement (BPA), the NHLBI plans to use Contractor resources for creating system cybersecurity documents and artifacts, for independently assessing those documents and artifacts and implementing ATOs, and for providing services that improve the NHLBI cybersecurity program. NHLBI plans to award Task 1, 3, 4, 5, and 6 to one vendor. Task 2 will be awarded to a separate vendor to maintain independence in the assessments conducted within this BPA. A vendor cannot be awarded both task orders. NHLBI may utilize these services to achieve the objective of improving the security of information systems and ensuring compliance with applicable federal, agency, and NIH security standards and best practices. Multiple Contractors will provide services through the BPA utilizing a fair opportunity process for each task order award. The Contractors providing services through this BPA shall develop a thorough familiarization with the missions of the various ICs, OD, and programs that will issue task orders through this BPA